STRESS INDUCED NEUROINFLAMMATORY CHANGES IN INTERSTITIAL CYSTITIS PATIENTS

This study will compare the effect of experimentally induced stress on inflammatory mediators and neuroendocrine responses of patients with interstitial cystitis and healthy controls.